In situ spatial characterization of CNS HIV-host cellular interactions from victims of sudden death

SUMMARY/ABSTRACT
In people with HIV (PWH) the central nervous system (CNS) harbors an HIV reservoir that may lead to ongoing
inflammation and tissue damage. PWH also have high rates of methamphetamine use which may act in
synergy with HIV persistence in the CNS to increase myeloid immune inflammasome activation, astrocyte
dysfunction, and neuroinflammation. However, the extent to which HIV-infected cells persist in the CNS in the
setting of ART and interact with local tissue environments that mediate inflammation with or without
methamphetamine use in vivo is largely unknown. Direct access to CNS tissue in healthy PWH on ART is
nearly impossible, yet in-depth spatial viral-host characterization within brain from PWH on ART with minimal
comorbidities is crucially needed to facilitate research on HIV-mediated neuroinflammation in the setting of
drug use. We established the longitudinal POstmortem Systematic InvesTigation of Sudden Cardiac Death
(POST SCD) Study, a prospective, countywide postmortem study to bank extensive samples and autopsy data
on all victims of sudden death in San Francisco County, including PWH. To date we have collected extensive
samples including brain from >85 PWH, ~80% on ART, and >700 uninfected individuals without major
underlying morbidity at the time of their unexpected out-of-hospital sudden death. As a result, the HIV POST
SCD cohort is a one-of-kind resource for the in-situ study HIV infection in the CNS in the setting of controlled
HIV disease. Well-curated brain tissue from multiple locations from PWH on ART have been collected and we
have generated preliminary directly in these tissues using high-dimensional spatial genomics demonstrating
that myeloid cells harboring HIV transcripts have unique genomic and transcriptomic phenotypes. We plan to
leverage the highly unique and comprehensive POST SCD cohort to provide unparalleled insight into the
nature and extent of HIV and methamphetamine use in the brain and host-immune factors that facilitate
inflammation and brain injury. In the R61 phase, we will develop and implement innovative single-cell
immunohistochemical, in situ hybridization, digital spatial gene expression, and quantitative drug assays. In the
R33 phase these analytical frameworks will be applied to brain tissue from PWH on ART and matched HIV-
sudden death cases with and without methamphetamine use. Our aims are to (1) implement innovative spatial
multi-omic assays that combine analysis of the localization, distribution, and transcriptional and translational
activity of HIV-infected cells and cellular host responses in multiple brain regions from PWH that died suddenly
out of hospital with minimal comorbidities; (2) test the hypothesis that in-situ immunohistochemistry can be
used in combination with high-parameter spatial profiling to quantify methamphetamine and ART levels in-situ
and to determine the impact of drug levels on HIV-host responses; and (3) test the hypothesis that
methamphetamine use acts in synergy with HIV to enhance myeloid immune cell inflammatory signaling and
altered astrocyte function leading to neuroinflammation and neural injury.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to study the impact of HIV-1 persistence and methamphetamine on central nervous system inflammation and injury in brain tissue from people with HIV that died suddenly out of hospital. We will leverage the unique San Francisco POstmortem Systematic InvesTigation of Sudden Cardiac Death (POST SCD) study for in-depth virus-host-drug interaction studies directly in the brain.